Research Training in Digestive Diseases

PROJECT SUMMARY
The GI training program of the Massachusetts General Hospital (MGH) remains dedicated to the preparation of
investigators committed to a career in GI biomedical research. This program continues to build on its extensive
past experience in training productive and committed digestive diseases investigators (>95% of trainees in past
10 years remain in academic GI). Fundamental features of the post-doctoral training format, the major
component of this program, include direct research participation in conjunction with a comprehensive program
of didactic instruction and enrichment activities to provide a deep foundation in biomedical science and modern
research techniques. In addition, continuation of a typically 1-2 year pre-doctoral laboratory research program
is proposed to attract promising underrepresented minorities, to careers in GI research at a critical juncture in
their careers.
Research Areas and Disciplines. The strength of the research base of this program encompasses a spectrum
of research interests. The majority of trainees will undertake training in laboratory research in which emphasis
is placed on the application of tools of molecular biology to GI research. Training is offered in several disciplines
central to the study of digestive diseases: Epithelial Biology, Developmental Biology, Immunology, Metabolism,
Host-Pathogen Interactions, Genetics, Cancer Biology, Stem Cell Biology, Systems Biology, the Microbiome,
and Tissue Engineering. For fellows undertaking training in clinical investigation, a rigorous preparation in
relevant quantitative sciences, including Biostatistics and Epidemiology, Biomedical Informatics and Population
Health, is provided. In all disciplines, updated formal work in the Responsible Conduct of Research is offered.
Level of Training, Background and Numbers of Trainees. This renewal proposes both post-doctoral and
pre-doctoral training. Post-doctoral training is offered to individuals holding M.D., M.D.-Ph.D. or relevant Ph.D.
degrees. Seven post-doctoral positions are requested: four post-doctoral fellows will begin training each year,
and remain in research training for a minimum of two years supported by this award. In addition, two positions
are requested to continue the pre-doctoral training fellowship for URMs completing an undergraduate degree or
enrolled in graduate or medical school, each student entering for a 1-2 year period.
Training Facilities. Research training will take place in the existing laboratories of the research mentors; a
group of 54 established investigators with extensive ongoing interactions. Laboratories are present at the MGH,
a large general hospital with more than 1,300,000 sq. ft. of space dedicated to research. In addition, training
opportunities will be available in laboratories elsewhere at Harvard, M.I.T., the Whitehead Institute, the Ragon
Institute, and the Broad Institute. Didactic educational programs will include those offered through the Harvard
Medical School, other affiliates of the Harvard Medical School, the Harvard School of Public Health, Harvard
University and M.I.T.

Public health relevance
PROJECT NARRATIVE The training of the next generation of knowledge creators in digestive diseases will require concerted efforts to harness the explosion of information that has been created by advances in genomics, functional genomics, network analysis, stem cell biology, the human microbiome, and other technologies. Now more than ever, a planned approach to the research career development of physician scientists – one that must incorporate solid scientific environment, mentorship, didactic curriculum, monitoring, and inter action – becomes critical to maximize likelihood of success. To preserve a training environment that, despite a challenging funding environment, has continued an exceptional track record of producing leaders in academic gastroenterology, we have retained preceptors from a stellar group of fundamental, translational and clinical scientists who have adapted and incorporated these recent advances while also having actively participated in mentoring.